Administrative Core

The Administrative Core supports the Research, Facility v and Community Outreach and Education Cores of the HSPH NIEHS Center for Environmental Health (the Harvard-NIEHS Center) through coordination (Executive Committee), fiscal management, external review (External Fiqure 6-1. Conceptual Structure of Harvard-NIEHS Center Advisory Committee), and support (Pilot Projects and Career Development). (See organizational, budgeting and reporting aspects of the Center and provides the leadership for scientific and programmatic activities. This Core is responsible for coordination and integration of Center components and activities.